Core F: Data Management and Analysis Core (DMAC)

Project Summary
The Data Management and Analysis Core (DMAC) will support the Baylor-Rice Superfund
Research Program (SRP) by providing advanced tools and infrastructure for data management,
exploratory and integrative data analysis, and hypothesis generation. DMAC will act as a hub
for biomedical projects P2 and P3 and engineering projects P1 and P4. A change in the current
renewal is that the DMAC will be led by Dr Cristian Coarfa; he has been Director of Multi-Omics
Analysis Core for the BCM Advanced Technology Cores since 2014. DMAC will be co-led by Dr
Susan Hilsenbeck who has acted as Director of Biostatistics and Bioinformatics Shared
Resource for the Dan L Duncan Comprehensive Cancer Center for the past 20 years. The
DMAC provides data management for all SRP projects, acting as a central SRP resource for
storage and access for all chemical, physical, biological, phenotypic, and multi-omics data
generated by the SRP projects. DMAC will define and execute quality assurance, using best
practices per data type, and store QA/QC for primary data, secondary data, and analysis
results. DMAC will define and implement a comprehensive Data Management Plan (DMP),
leveraging the biobanking experience and resources at the Dan L Duncan Comprehensive
Cancer Center, including sample metadata and omics data. DMAC will function as a data
management hub for the Administration Core (AC), the Community Engagement Core (CEC),
the Research Experience and Training Coordination Core (RETCC), the Research Support
Cores (RSC-I, RSC-II). DMAC will enable data integration across all SRP, harnessing methods
such as GPU-supported deep learning. In coordination with RETCC, the DMAC will conduct
training in biostatistics and bioinformatics for graduate students and postdocs working on BCM-
Rice SRP projects and will provide the computing and web infrastructure for workshops and
seminars. DMAC will interact with the AC and RETCC to support training and technology
transfer activities that deliver new findings and analytical tools to scientific community. DMAC
will support the CEC to deposit community engagement documents and enable SRP data
access by the Superfund sites communities. To achieve its critical goals, DMAC has the
following aims: 1) Implement a robust and comprehensive Data Management Plan; 2) provide
expert analysis and consultation in the specialized areas of statistics and bioinformatics for all
Projects; 3) Develop and deploy of a framework supporting deep and multi-level data
integration; 4) Conduct education and training in statistics, multi-omics bioinformatics, and data
science for graduate students and postdoctoral fellows involved in Superfund related research.

Public health relevance
Project narrative The Data Management and Analysis Core provides comprehensive and essential data management support, bioinformatics analysis, statistical consultation and assistance with education to Projects and Cores of the Superfund Research. It will implement a relatively simple but comprehensive Data Management Plan (DMP). The combined data analyses and integration have the potential to lead to novel mechanistic insights that would not be apparent to individual projects or cores.